MOTIVATING DETOXIFIED ALCOHOL USERS TO ENTER AFTERCARE

In response to RFA AA-94-05, released by NIAAA, this health services research application will test the efficacy of a brief intervention designed to enhance the treatment entry rates of detoxified alcohol users. Although detoxification units provide short-term relief from addiction, they are less successful in their other stated objective of motivating patients to enter long term treatment or aftercare. This study will test the effectiveness of a brief motivational intervention designed to enhance the likelihood that alcohol users, will soon thereafter enter chemical dependency treatment. Specifically, the investigation will further develop and test the feasibility and effectiveness of a motivational enhancement package, modified from the version that has shown promise across several settings. Designed in response to the need for improved outcomes following detoxification and for understanding of the role of detoxification in the range of services for chemically dependent persons, the investigation will shed light on a relatively unexamined treatment arena. Conducted in a hospital in the South Bronx, the 1 year investigation will include-three phases: 1) Development-- including semi-structured interviews and focus groups with detox patients, staff, and 12-step members; discussions and brief instrument testing with staff from treatment programs; 2) Pilot intervention with 75 motivational and 75 control participants; and 3) Data analysis, dissemination, and feedback to and from service providers. In the pilot study, a cohort of new patients entering the unit over a two week period would be assigned to an experimental condition--two motivational sessions delivered in the detoxification unit. After the quota is filled, and for the next week, entering patients would not be in the study. Then, for the subsequent two weeks, the next cohort of patients enter the study as controls. The cycle is repeated over six months, with each condition separated by a "wash-out" period. Subjects will be measured at baseline, and at 2 and 12 weeks post-discharge. The study will employ intervention, measurement, and follow-up protocols that build upon existing theory and research, but which also have immediate relevance to the providers of treatment services. The research will be led by investigators from Columbia University, and will be conducted collaboratively with staff and investigators from St. Barnabas Hospital.